Nutritional Cu Signaling and Homeostasis

7. Project Summary / Abstract
Copper (Cu) is an essential micronutrient for nearly all forms of aerobic life because of its participation in key
redox reactions and reactions of O2 chemistry. Cu deficiency, accordingly, has an impact on multiple metabolic
and developmental pathways. Cu deficiency in animals and humans occurs because of genetic defects or in
situations of malnutrition. In previous work, Merchant and co-workers, using a model organism, Chlamydomonas
(an alga in the green lineage), discovered fundamental mechanisms and regulatory circuits for maintaining Cu
homeostasis that are broadly relevant. Specifically, the group showed that an abundant Cu protein, plastocyanin,
is replaced by an iron-containing heme protein, cytochrome (Cyt) c6, when Cu is scarce. The Cu that is spared
by this replacement is “upcycled” for use in Cyt oxidase in respiration. This switch allows maintenance of two
important bioenergetic pathways – photosynthesis and respiration. Genetic analysis identified a Cu-response
regulator (CRR1), a transcription factor that activates the CYC6 gene encoding Cyt c6 through associated Cu
response elements (CuREs) as well as ~64 other genes that form the nutritional Cu regulon, including
assimilatory Cu(I) transporters CTR1 and CTR2, enzymes of heme biosynthesis, and other factors that enable
Cu allocation to Cyt oxidase and that adjust thylakoid membrane properties to accommodate the substitute
protein. In this project period, the focus is on how CRR1 is turned off for tight homeostatic regulation of Cu
metabolism. In the working model, supported by substantial preliminary data, CRR1 activates the Cu regulon in
deficiency, while upon Cu supplementation, the protein is post-translationally modified, which marks CRR1 for
recognition and ubiquitylation by CEHC1/FBXO3, a newly discovered F-box protein, followed by proteasome-
dependent degradation. In this context, there are 3 aims. 1) Post-translational modifications of CRR1 in +Cu
cells will be captured by LC-MS following immunoprecipitation of CRR1 under specific conditions where the
protein accumulates, as in the cehc1 mutant. The site(s) of modification will be tested for their impact on Cu-
responsive degradation of CRR1, individually and in combination, by site-directed mutagenesis of CRR1. 2)
Physical interaction between CEHC1 and CRR1 will be tested by co-localization and captured by co-
immunoprecipitation, and the substrate binding domain of CEHC1 will be identified by mutation and tested in
vitro for binding to the Cu dependent degron. Candidate CRR1 modification enzymes or other components in
this regulatory circuit, such as a Cu sensor, will be discovered by exploiting a powerful gain-of-function classical
genetic screen for constitutively active CRR1 using CuRE-reporter constructs. 3) The operation of a post-
translational mechanism to regulate Cu uptake by CTRs will be evaluated by using quantitative proteomics to
measure Cu-dependent changes in half-life and by monitoring sub-cellular localization as a function of Cu supply.
The execution of this project will complete our picture of nutritional Cu signaling and homeostasis through
discovery of the feedback loop that keeps CRR1 off in the Cu replete cells.

Public health relevance
8. Project Narrative Copper, because of its function as a redox cofactor and its prevalence in enzymes that catalyze reactions with oxygen (O2) or oxygenated substrates, is an essential micronutrient for most aerobic organisms, and hence for human health. Organisms sense nutritional Cu deficiency and respond by turning on a suite of genes, which in Chlamydomonas is dependent on a transcription factor, CRR1, to facilitate copper economy and copper- dependent metabolism. CRR1 is degraded and economy measures are turned off in copper-replete cells. In this project, the investigators will dissect the signaling pathway that responds to copper supply, leading potentially to the discovery of a copper sensor and a mechanistic understanding of the connection between copper-deficiency and hypoxia.